Validation of Swine Model for Testing a Novel Therapy for Postoperative Atrial Fibrillation using Nanoformulated Calcium Chloride to Suppress Cardiac Ganglionated Plexi

The goal of this proposal is to validate the feasibility of the swine model to test our novel therapy for the
prevention of postoperative atrial fibrillation (POAF). POAF is the most common complication from cardiac
surgery affecting 30%-50% of patients after coronary artery bypass grafting and/or valve surgeries. POAF
leads to increased heart failure and hospital stays, costing an excess of US$2 billion per annum. POAF is an
independent predictor of the development of AF long term. POAF is a highly prevalent issue in the veteran
population. We recently reported a 40% incidence of POAF at our institution, with a 30% 5-year risk of
recurrence of AF compared to 3% without POAF. Overactivity of the cardiac autonomic nervous system
(CANS), is an important substrate for both POAF and AF. We hypothesize that neuromodulation of CANS can
suppress POAF. We recently published in a canine model of POAF, that microinjection of nanoformulated
CaCl2 into cardiac ganglionated plexi (GP), a critical component of the CANS, during open heart surgery,
suppresses/prevents POAF. The mechanism of action is by inducing neuronal apoptosis in GP thus protecting
the heart from sympathetic surge and inducing reverse remodeling of the heart, with potentially long term
suppression of AF.7 The goals of this proposal are to (a) validate our successful canine model of POAF in
Yucatan miniature swine species (b) test the safety and efficacy of nCaCl2 for neuromodulation and
suppression POAF vulnerability in swine. Validating the swine model facilitates clinical translation of our novel
therapy with the significance of targeted, effective and safe therapy for POAF and potentially long term
suppression of AF vulnerability in a high-risk population.

Public health relevance
Post-operative atrial fibrillation (POAF) affects 30%-50% of patients after coronary artery bypass grafting and/or valve surgeries. POAF leads to increased heart failure, hospital stays, healthcare expenditures and predicts the development of late AF. Increased activity of the cardiac ganglionated plexi (GP), a key component of the cardiac autonomic nervous system (CANS), is an important trigger and substrate for POAF and AF. We recently published in a canine model, that microinjection of nanoformulated CaCl2 into GP induces neuronal apoptosis, dampens the overactivity of the CANS that occurs after cardiac surgery and suppresses/prevents POAF without adverse effects or myocardial damage. Our goal is to validate the feasibility of our canine POAF model in swine species, to test the safety, efficacy and neuromodulation mechanism of POAF suppression by nanoformulated CaCl2.The potential benefits is a safe, effective and cost- effective method to prevent POAF and reduce susceptibility to AF long term.